Epigenetic regulation of embryonic stem cell biology by Tet enzymes

ABSTRACT
The central goal of my research program is to establish the epigenetic mechanisms of gene regulation that
govern the biology of embryonic stem cells (ESCs). We are interested in defining how ESC gene expression
programs and biology are regulated by DNA methylation and the Tet family of DNA demethylases. Tet enzymes
oxidize 5-methylcytosine (5mC) to 5-hydroxymethylcytosine (5hmC), 5-formylcytosine (5fC), and 5-
carboxylcytosine (5caC) in a step-wise manner. 5fC and 5caC are removed from the genome by the DNA repair
machinery leading to active DNA demethylation. The conventional understanding in the field has been that Tet-
mediated stepwise oxidation of 5mC mainly promotes DNA demethylation. However, the stability and abundance
of 5hmC in ESCs and other cell types suggests that not all DNA hydroxylation leads to DNA demethylation. This
poses a major question in the field that DNA hydroxylation and the base 5hmC may have gene regulatory
functions besides being an intermediate in DNA demethylation. We hypothesize that the early DNA hydroxylation
and the later formylation/carboxylation activities of Tet enzymes uniquely regulate gene expression programs in
ESCs, and have distinct contributions to the developmental potential of ESCs. We also hypothesize that 5hmC
may serve as an independent epigenetic mark having its own readers and impact on gene regulation. We will
pursue these hypotheses in the context of two projects. The first project will dissect the molecular and biological
requirements of Tet-driven DNA hydroxylation vs. formylation/carboxylation in ESCs biology. The second project
will identify readers of 5hmC and the potential of 5hmC as an independent epigenetic mark in regulation of ESC
biology. This work builds logically on our prior work and expertise in defining Tet-mediated epigenetic regulation
of gene expression in stem cell biology and development. Our findings will establish new layers of epigenetic
regulation by Tet enzymes, which is otherwise canonically thought to be only DNA demethylation. Knowing which
Tet enzymatic activity or which of these modified bases is the most important for pluripotency network and
differentiation will help us better target Tets to enhance ESC applications in regenerative medicine. Moreover,
identifying novel readers of 5hmC can help us better understand gene regulatory mechanisms in ESCs. Our
findings will also have implications for the etiology of human diseases where Tet enzymes are mutated/
dysregulated or 5hmC levels are perturbed, and identify the relevant Tet activities for therapeutic targeting.

Public health relevance
PROJECT NARRATIVE Embryonic stem cells (ESCs) and induced pluripotent stem cells (iPSCs) hold promise in regenerative medicine by virtue of their ability to give rise to any cell type in our body. Therefore, understanding their gene regulation and biology is of paramount significance to our health. ESC properties are regulated by epigenetic modifications in the genome that control gene expression. This proposal studies the role of an important family of epigenetic modifiers (Tet enzymes) and their various enzymatic functions in regulation of ESC gene expression programs and biology. Our findings will have implications not only for understanding gene regulation and ESC biology but also in diseases where Tet enzymes are deregulated.